Bioluminescent FAK Sensor and Genome-Wide CRISPR Knockout Screen to Identify Regulators of Cellular Adhesion

This project leverages a combination of bioluminescence-controlled transcription and robust genome-wide CRISPR screening, the research will map the regulation of Focal Adhesion Kinase (FAK) activity and help elucidate the complex genetic networks that govern cellular adhesion and locomotion, advancing the field of cellular biology.
The project is structured to make a significant impact in several ways. Firstly, by developing a bioluminescent kinase sensor, BlinKS, for FAK, the project aims to provide real-time insights into kinase activity within living cells, a breakthrough in observing dynamic cellular processes. The integration of this sensor with genome-wide CRISPR knockout screens will enable the identification of novel genes that regulate FAK signaling pathways. This could potentially lead to the discovery of new molecular targets for therapies in diseases where FAK plays a crucial role, such cancer metastasis and wound healing.

Public health relevance
This project at Central Michigan University (CMU) harnesses innovative bioluminescent kinase sensor technology, BlinKS, to elucidate the regulatory mechanisms of Focal Adhesion Kinase (FAK), a key player in cellular adhesion and motility. By integrating a FAK sensor with genome-wide CRISPR knockout screens, the project aims to identify novel genes that influence FAK signaling pathways. Identification of novel FAK regulators may lead to positive public health benefits by providing new therapeutic interventions in diseases like cancer metastasis and wound healing.